Body composition and breast cancer survival: immune and metabolic biomarkers in breast tumors

ABSTRACT
There is growing evidence that breast cancer patients with adverse body composition (low muscle mass and
excess adiposity) have worse therapeutic responses and an increased risk of recurrence and death. Both low
muscle mass and excess adiposity promote systemic metabolic abnormalities like the metabolic syndrome.
While the impact of adverse body composition on the local tumor microenvironment remains unclear, data from
pre-clinical animal models and in vitro analyses suggest that adverse body composition could contribute to
impaired anti-tumor immunity and alterations in metabolic and proliferative signaling pathways. However, these
relationships have not been comprehensively studied in human breast cancer patients or within molecular
subtypes of breast cancer that have differing biology and prognosis. Developing and personalizing breast
cancer therapies will require understanding how systemic factors such as patient body composition and the
metabolic syndrome impact the local breast tumor microenvironment and therefore breast cancer survival. To
address this gap in knowledge, we propose a molecular epidemiologic study to determine if lower muscle
mass, excess adiposity and the metabolic syndrome impair the anti-tumor immune response by promoting T-
cell exhaustion (Aim 1) and/or by altering the activity of PI3K/AKT/mTOR pathways and proliferative signaling
(Aim 2) in the breast tumor microenvironment. We will further determine if alterations in these immune,
metabolic and proliferative signaling pathways mediate the association of adverse body composition with
breast cancer recurrence and breast cancer-specific mortality (Aim 3). To accomplish this, we will measure
gene expression levels in 1,400 archived clinical breast tumor samples selected from a unique cohort: more
than 4,000 stage II and III breast cancer patients with longitudinal follow-up and precise measures of muscle,
subcutaneous, and visceral adipose tissue. All these patients also have rich electronic medical record data on
cancer treatments and the metabolic syndrome. Since our sampling approach ensures representation across
each of four major clinicopathological categories defined by hormone receptor and human epidermal growth
factor receptor 2 status, we will be able to examine associations overall, and separately within each breast
cancer subtype. Using this premier data resource, we will examine how differences in the breast tumor
microenvironment caused by adverse body composition and the metabolic syndrome may mediate differences
in long-term breast cancer outcomes. The proposed study will help personalize existing breast cancer
therapies and develop future intervention approaches that consider both the molecular features of the tumor
and patient body composition. Furthermore, this study will identify tumor biomarkers that are appropriate
targets to be measured in future trials to improve body composition and the metabolic syndrome through
pharmacologic or lifestyle intervention.

Public health relevance
NARRATIVE This proposal will answer two important questions about breast cancer. First, does a cancer patient’s muscle and fat mass affect the biologic characteristics of their tumor, and, second, does a tumor’s biology explain the relationship of muscle and fat mass to oncologic outcomes, specifically the risk of the cancer coming back or the patient dying of breast cancer. These answers could allow us to develop new treatments for cancer patients.